Training Grant in Molecular Imaging Research

? DESCRIPTION (provided by applicant):The long term goals of this T32 post-doctoral Training Program are two-fold: i) To recruit the best and brightest young research and/or clinical trainees interested in successful academic careers employing the state-of-the art in vivo imaging tools, complementary methods for detecting molecular and cellular processes in vivo and systems-wide analyses; and ii) To provide these high quality trainees with a period of funding so they can be exposed to: a) pressing cancer problems today; b) the most innovative and cutting-edge tools with which to attack these problems; c) optimal didactic experiences; and d) carefully mentored research experiences during periods of increasing autonomy. Taken together, this T32 is entirely cancer focused, innovative in its science and training approach and unique. It has provided our trainees with the foundational experiences necessary to achieve independence in research as is attested to by the track record of previous trainees. The current training grant is in its fourteenth year of funding and has had a total of 42 trainees, 8 of whom are still in trainig. Thirty-four trainees have graduated from the program, the majority of whom are now in academia. Overall, trainees have published over 230 peer-reviewed publications to date. The faculty of 34 mentors has been carefully selected by the Program Directors (PDs) over the last 10 years on the basis of their demonstrated commitment to the independence of their trainees, exciting and important biologic problems on which to work, and stable funding. The faculty are all highly accomplished and currently receive over 200 extramural research grants. More recently, the training program has been considerably strengthened by a) expanded thematic programs (e.g. systems pharmacology, nanotechnology and drug delivery, immunotherapies, single cell analyses), b) new lecture series, c) an expanded imaging facility. With our current faculty, enhanced facilities, scope of supported research and past accomplishments, we offer an outstanding research environment for the next generation of clinicians and scientists to be trained in molecular imaging and systems analysis.

Public health relevance
PUBLIC HEALTH RELEVANCE: This postdoctoral training program seeks to take outstanding scientists and/or physicians who desire careers in academic medicine and immerse them in intensive training under the tutelage of dedicated training faculty in the field of molecular imaging and cancer systems analysis. Currently, few opportunities currently exist that provide broad, in-depth and interdisciplinary training for individuals to develop and validate novel and non- invasive methods capable of detecting molecular and cellular processes in vivo, and which could ultimately be used in patients.